Catheter-injectable system for local drug delivery after myocardial infarct

PROJECT SUMMARY
Myocardial infarction (MI) is a leading cause of cardiovascular disease and death. After an MI, limited
regeneration occurs, and instead, inflammation and scarring cause the affected myocardial tissue to turn fibrotic
and thin. This tissue remodeling results in abnormal tissue mechanics and impaired cardiac function, often
leading to heart failure and death. Therefore, a promising therapeutic approach is to reduce inflammation and
the adverse tissue remodeling of the infarct zone. Unfortunately, many emerging drug candidates to achieve
these goals require prolonged dosing over multiple weeks, greatly limiting their clinical translation. To overcome
this challenge, I propose the development of a hydrogel that is catheter-injectable and enables the one-time
injection of a drug payload into the myocardium for long-term release. This multidisciplinary project merges my
expertise in drug delivery, polymeric materials, and cardiovascular bioengineering. Specifically, I propose a
nanoparticle-based, therapy-eluting gel that will be retained within the contractile myocardium to locally deliver
the chosen therapy at a controlled rate. This hydrogel will address two challenges in cardiovascular therapies 1)
retention in the myocardium due to the mechanically active heart and 2) delivery of a sustained therapeutic dose
that preserves the bioactivity in the harsh environment of the infarct zone. In this project, I propose to deliver two
potential therapeutics investigated in clinical trials to address inflammation and adverse remodeling. Anakinra
delivered daily through subcutaneous injection has emerged as a promising candidate to reduce inflammation
and prevent cardiomyocyte apoptosis after MI. Fresolimumab has potential to mitigate heart failure after MI by
preventing fibroblast activation into myofibroblasts and thereby limiting fibrosis. However, to elicit a therapeutic
effect, these drugs must be present for an extended duration via multiple daily injections. Therefore, novel
therapeutics like Anakinra and Fresolimumab are limited in efficacy and clinical use and would greatly benefit
from materials science approaches that would reduce the need for painful daily injections by enabling them to
be delivered locally within the myocardium in a reservoir that can protect their bioactivity, limit their off-target
effects, and offer tunable release kinetics that can match the therapeutic window of the chosen drugs. In the K99
mentored phase of this grant, I will develop the catheter-injectable hydrogel and demonstrate retention within
the myocardium (Aim 1), tailor the release kinetics of the nanoparticles to achieve both rapid and sustained
payload delivery of Anakinra (Aims 2), and demonstrate the therapeutic effect in a preclinical rat model of MI
(Aim 3). In the R00 phase, the modular hydrogel technology will be expanded to include a second type of
nanoparticle to enable the combinatorial release of Anakinra and Fresolimumab (hydrophobic and hydrophilic
drugs, respectively) (Aim 4) and improve heart function quantitatively after an MI by preventing adverse
remodeling in a rat preclinical model (Aim 5).

Public health relevance
NARRATIVE I propose the development of a nanoparticle therapy-eluting gel that overcomes two critical challenges in myocardial drug delivery: (1) rapid diffusion away from the infarct zone due to the mechanically active heart and (2) delivery of a sustained therapeutic dosage that maintains its bioactivity. For this work, I propose the delivery of two emerging therapeutics, Anakinra, and Fresolimumab, as these two agents have been shown in clinical studies to prevent adverse remodeling of the infarct zone and would greatly benefit from controlled local delivery to avoid toxicity and off-target effects. The proposed platform is modular and can be easily tuned to deliver a range of therapeutics, allowing us to quickly adapt to new pharmacology advances and therapeutic approaches as they are developed.